Amyloid PET and Blood-Based Biomarkers of AD among Diverse Populations

PROJECT SUMMARY/ABSTRACT
This application for a K23 career development award for Charles Windon, MD, will support his long-term goal
of becoming an independent clinical researcher. Dr. Windon is a behavioral neurologist and Assistant
Professor in the Department of Neurology at the University of California, San Francisco, within the Memory and
Aging Center (UCSF MAC). He seeks to become an independent investigator in the field of biomarker-
informed inequities research and address inequities in Alzheimer’s Disease and Related Dementias
(AD/ADRD). The support provided by this K23 will allow Dr. Windon to achieve the following training goals
(TG): TG1: knowledge in PET imaging analysis and plasma biomarker analysis; TG2: advanced statistical
methodology knowledge for high complexity imaging and clinical data; TG3: skill building in analytic
approaches to individual- and neighborhood-level SDOH; and TG4: grantsmanship, dissemination of clinical
research, and other areas of professional development. He will incorporate the findings of his K23 into an R01
that develops and explores models validated in larger cohorts more richly characterized by SDOH measures
and Alzheimer’s Disease and related dementias (AD/ADRD) biomarkers to best identify which pathological
contributions to cognitive impairment should be emphasized in therapy for ethnoculturally diverse individuals.
Dr. Gil Rabinovici, a world recognized leader in amyloid PET and fluid AD/ADRD biomarkers, will serve as
primary mentor for this K23. He is joined by co-mentor Dr. Jacqueline Torres, a social epidemiologist who has
extensive expertise in advanced epidemiologic and econometric methods to examine social determinants and
inequities in AD/ADRD. Dr. Adam Boxer, an experienced researcher and clinical trials leader with expertise in
blood-based biomarkers of AD/ADRD, Dr. Isabel Allen, an experienced professor with expertise in statistical
analysis, and Dr. Amy Kind, a leading expert in neighborhood level social determinants, are collaborators.
Dr. Windon will investigate in this proposal how global β-amyloid burden, measured by PET, and blood-based
phosphorylated tau (p-tau) 217 and Neurofilament light (NfL) biomarkers are independently associated with
AD/ADRD among diverse populations with varying social determinants of health (SDOH) profiles. Analysis of
>2900 cognitively impaired diverse individuals with these biomarkers will be used for specific aims of: 1)
Understanding differences in clinical presentation, dementia risk factors, SDOH profile, and rates of amyloid
PET positivity between cognitively impaired Black/African American and Latinx individuals and Non-Latinx
White individuals; 2) Understanding differences in β-amyloid burden by PET centiloid value between
cognitively impaired Black/African American and Latinx and Non-Latinx White individuals and quantify
relationships between p-tau 217 and NfL, respectively, and cognitive impairment among these groups; 3)
Testing whether individual-level SDOH or neighborhood-level SDOH act as effect modifiers in the relationship
between p-tau 217 and NfL and PET centiloid value, respectively, and cognition.

Public health relevance
PROJECT NARRATIVE Disproportionate rates of clinical Alzheimer’s Disease and Related Dementias (AD/ADRD) among African American and Latinx individuals are driven by complex mechanisms that involve social determinants of health, amyloid, tau, and other factors. This proposal will examine multimodal biomarker data from an ethnoculturally diverse group of individuals from across the US to understand relationships between social determinants of health and biomarkers of AD/ADRD pathology and how these different pathologies contribute to cognitive impairment and AD/ADRD clinical presentation. This project will provide foundational knowledge to improve our understanding of the etiological underpinnings of inequities in clinical AD/ADRD, thereby allowing for the development of more effective interventions to address them.